Center for Modeling Non-Coding Disease Variants: Resource and Service Core

PROJECT SUMMARY/ABSTRACT: RESOURCE AND SERVICE CORE
Non-coding variants in disease have long been understudied due to the complexity of understanding their
function, the lack of accessible tools to analyze them, and their tissue- and development-specific effects. The
primary goal of the Resource and Service Section (RSS) Core is to bridge the Center for Modeling Non-Coding
Disease Variants with the broader scientific community by providing a user-friendly platform for researchers to
access cutting-edge resources for non-coding variant prioritization and disease modeling to alleviate the
challenges associated with studying disease-associated non-coding variants. The RSS Core will collaborate
closely with the Center's Bioinformatics Core to develop an intuitive web-based interface that allows researchers
to input non-coding variants of interest and explore a range of outcomes, including conservation, tissue- and
development-specific expression patterns, and functional screening results. This will lead to dedicated pages
where researchers can directly order mouse models or human pluripotent stem cell (hPSC) models tailored for
their studies. The RSS Core will support the distribution of disease models to researchers by (1) importing mice
from the Disease Modeling Core, conducting independent validation, and assessing their health status, (2)
generating hPSC disease models and differentiating them into relevant cell types, (3) cryopreserving, storing,
and cataloging each biological resource, (4) distributing these resources on a fee-for-service basis, and (5)
coordinating with the Mutant Mouse Resource and Research Centers to ensure a seamless transition of models
from the RSS to the broader research community.